The Stanford Clinical Center for the Study of Type 1 Diabetes in Acute Pancreatitis

Project Summary/Abstract
The Stanford Clinical Center applies to participate in the Type 1 Diabetes in Acute Pancreatitis
Consortium (T1DAPC), to contribute its established clinical and research infrastructure in acute
pancreatitis and expertise in pancreatology, endocrinology, and immunology. Our group is well-
positioned to develop a prospective cohort of patients with acute pancreatitis to support human based
studies investigating the relationship of diabetes, with a particular focus in Type 1 diabetes mellitus
(T1D), in acute pancreatitis. In response to the research objectives of the T1DAPC as outlined in this
RFA, we have formed a strong complementary scientific team. Our proposal is highly responsive to
the RFA in several specific ways. The Stanford Clinical Center has the capacity and infrastructure to
effectively recruit patients into this prospective cohort of acute pancreatitis patients. Second, We
propose to use prospectively collected bio-specimens from this cohort to examine the role of the
immune system in acute pancreatitis and its relationship to the development of diabetes. Third, we
propose to look at hormonal changes associated with post-pancreatitis diabetes (PPDM) as well as
the potential relationship between PPDM and exocrine pancreatic insufficiency. The opportunity to
pursue these investigations in collaboration with other centers as a Consortium is an exciting novel
opportunity to study acute pancreatitis and its relationship with type 1 diabetes.

Public health relevance
PROJECT NARRATIVE The Stanford Clinical Center will lead and actively recruit patients into the Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC). Collected specimens from this cohort will be studied to develop new immunological and hormonal insights into the relationship between acute pancreatitis and diabetes, in particular type 1 diabetes mellitus. These insights will inform new diagnostic tests and treatments.